CRYSTALLIN GENES--STRUCTURE, ORGANIZATION, EXPRESSION, AND EVOLUTION

Crystallins are a diverse group of multifunctional, water-soluble proteins that are preferentially expressed in the eye lens and often, to a lesser extent, in other tissues. We have shown recently in transgenic mice that a 4.5 kbp promoter fragment of the alphaB-crystallin/small heat shock protein gene mimics the complex regulatory pattern of the endogenous gene, with expression in lens, heart, muscle, and other tissues. Site-specific mutagenesis experiments utilizing transgenic mice showed that the alphaB-crystallin TATA box is not required for lens-specificity but is utilized preferentially for expression in the lens. Cotransfection and transgenic mouse experiments demonstrated that expression in the lens fibers can be driven by a 208 bp promoter fragment that contains two lens-specific cis-elements (LSR1 and LSR2) which can be activated by Pax-6 and RAR beta/RXRbeta. While Pax-6 also activates the alphaA, zeta and delta-crystallin genes, we found it represses the chicken betaB1 and betaA3/A1-crystallin genes. Pax-6 represses the betaB1 promoter by binding to a lens-specific cis-element (PL-2); Pax-6 repression does not require the C-terminal domain but does require binding by the paired and homeodomain. PL-2 binds a different element to activate the betaB1 promoter. We thus suggest that Pax-6 prevents the expression of betaB1 and betaA3/A1-crystallin promoters in lens epithelial cells and attenuates expression in lens fiber cells by limiting the access of transcriptional activators to these promoters. Another homeodomain protein, Prox-1, which we cloned last year, is able to activate the betaB1-crystallin promoter in transfection experiments; the mechanism remains unknown. Transgenic mouse and transfection experiments have also revealed other activating element and enhancers responsible for the high expression of the chicken betaB1 and betaA3/A1-crystallin genes. Protein binding tests showed that Pax-6 can complex in vivo and in vitro with retinoblastoma protein (pRB) and the TATA box binding protein (TBP) via the Pax-6 homeodomain. Cotransfection experiments showed that pRB downregulates the alphaA-crystallin promoter in the presence of Pax-6, suggesting a functional interaction between Pax-6 and pRB. Since Pax-6 is expressed preferentially in the lens epithelium and pRB is expressed preferentially in the fibers, our data suggest that Pax-6 and pRB may participate in overlapping regulatory pathways controlling epithelial cell division, fiber cell elongation and crystallin gene expression during lens development. Several other contributions have been made this FY. These include the following. (1) The demonstration that USF contributes to activation of the mouse alphaA-crystallin promoter by binding to the conserved +1 site. (2) The cloning of a putative transcription factor (Kid-1) with 13 zinc-fingers and a Kruppel domain expressed specifically in the kidney and eye of the mouse. (3) The derivation of a mouse trabecular meshwork cell line. (4) The demonstration that the scallop eye lens contains a single crystallin identical or related to aldehyde dehydrogenase. (5) In collaborative experiments with Drs. Zdenek Kostrouch and J. Edward Rall (NIDDKD, NIH) we have cloned an RXR cDNA and gene from jellyfish larvae. Moreover, we have successfully obtained jellyfish polyps from larvae captured in the wild that subsequently metamorphosed into swimming medusae under laboratory conditions. This opens the possibility of studying eye development in these primitive species.